SELECTED CYTOKINES IN BLOOD, AMNIOTIC FLUID AND CORD BLOOD OF PREGNANT WOMEN

The study will observe differences of activities of IL-1, IL-6 TNF and CSF-1 in the maternal blood, amniotic fluid and umbilical cord blood in pregnant women experiencing normal pregnancies and labor, preterm labor, and PROM and pregnancies complicated by fetal growth retardation (FGR).